An examination of the role of parental sensitivity and responsivity and learning opportunities in parent-mediated intervention for toddlers with autism spectrum disorder

PROJECT SUMMARY/ABSTRACT This training grant will build the trainee's research skills related to identification of active ingredients in autism intervention, community collaboration, and data analysis through completion of coursework, guided activities, and completion of a research project. Parents are increasingly called upon to assist with the delivery of early interventions for children with autism spectrum disorder (ASD). Two different evidence-based intervention approaches—structured behavioral interventions and naturalistic developmental behavioral interventions (NDBI)—are most frequently utilized. These approaches differ in the methods they emphasize in parent- delivery of the intervention. For instance, the parent delivery of structured behavioral intervention Discrete Trial Training (DTT) emphasizes the provision of learning opportunities—opportunities for the child to develop a skill, new or emerging—coupled with the learning principals of applied behavior analysis (ABA) to enhance child learning with limited attention to the caregiver/child relationship. In contrast, parent delivery of the Early Start Denver Model (ESDM), an NDBI, focuses on establishing an affectively rich caregiver interaction— by promoting sensitive and responsive parenting behaviors—and incorporates the learning principles of ABA into a subset of those interactions. These two interventions differ in their prioritization of the provision of learning opportunities and parent-child interaction. To our knowledge, no studies have compared parent implementation of structured behavioral and NDBI interventions. This study compares the parent-child interactions for parents of children with ASD who received coaching in positive behavior support strategies (DTT condition) and those coached in the manualized Parent Early Start Denver Model (P-ESDM) as part of a larger study in which children received intensive, therapist-implement treatment of either DTT or ESDM. Video recordings were collected monthly for 12 months of an object-play activity (e.g., toy play) between the parent and child. We will code months 1, 4, 8, and 12 for: (1) the quality of the parent-child interaction; (2) the variety, frequency, and quality of learning opportunities provided; and (3) the child's dyadic engagement with the goal of understanding the effects of intervention training on the parent-child interaction. An examination of change in parent behavior based on these different intervention approaches may help elucidate potential mechanisms of change for downstream child outcomes. Measuring the active ingredients across intervention approach may lead to a greater understanding of how best to support parents of children with ASD. This project will take place in an interdisciplinary training environment with an outstanding research infrastructure designed to support young scholars. As part of this fellowship, the trainee will receive training in parent coaching and parenting behavior that supports child development, statistical and behavioral coding methodology, the dissemination and communication of research findings to the community, and community partnered participatory research.

Public health relevance
PROJECT NARRATIVE This study compares the parent-child interactions for parents of children with autism spectrum disorder (ASD) who received coaching in positive behavior support strategies and those coached in a manualized naturalistic developmental behavioral intervention (NDBI), the Parent Early Start Denver Model (P-ESDM) as part of a larger study in which children received intensive, therapist-implement treatment using either a structured behavioral strategy, Discrete Trial Teaching (DTT) or Early Start Denver Model (ESDM). To our knowledge, no studies have compared parent implementation of structured behavioral and NDBI interventions despite the fact that the two approaches differ in the strategies they use to improve parent-child interactions. Measuring the active ingredients across intervention approaches may lead to a greater understanding of how best to support parents of children with ASD.